Mechanisms of Opiate Drug-HIV-Induced Neurodegeneration

DESCRIPTION (provided by applicant): Accumulating evidence suggests that opioid drug abuse per se directly exacerbates the neuropathology of HIV-1. Neuronal death is preceded by a prolonged period of synaptic culling and functional losses, and dendritic pathology that are presumably reversible. Opiate abuse potentiates the neuropathogenesis of HIV by synergistically increasing dendritic pathology (varicosity formation & pruning), while promoting spine losses (plasticity) in the striatum and hippocampal CA1 pyramidal neurons. Moreover, behavioral defects in both Morris water maze and rotarod performance coincide with synaptic losses and dendritic pathology in the absence of neuronal death, suggesting that neuronal injury and reduced synaptic connectivity underlie comorbid increases in HIV-associated neurological disorders (HAND). This represent a fundamental shift in our understanding of opioid drug action and propel the grant in novel directions. While death per se is significant, the interruption of events preceding neuron death may be more strategic therapeutically. We hypothesize that opioid-HIV interactive increases in neuron death are preceded by cumulative insults to synaptic organization and function that are non-lethal and assumed reversible. Aim 1 will characterize the events underlying opioid and HIV-1-dependent neuronal dysfunction and/or injury in hippocampal neurons. Aim 2 shall define the excitotoxic mechanisms by which opioids exacerbate HIV-1 Tat and gp120-induced neuronal dysfunction, injury, and/or death. Opioid and HIV-1-dependent alterations in synaptic function (altered membrane properties, EPSPs) spine morphology, and dendritic pathology (altered Na+, Ca2+, and ATP homeostasis) will be assessed. Lastly, aim 3 will identify the MOPr-expressing cellular sites of opioid action that exacerbate HIV-1-induced hippocampal neuronal injury, dysfunction and behavioral deficits in vivo. Cellular sites where opioids exacerbate Tat and gp120 actions in the hippocampus will be identified using floxed MOPr mice bred to astroglial specific GFAP, myeloid (microglial) specific lysozyme 2, and GABAergic forebrain neuron expressing Cre recombinase mice. Conditionally deleting MOPr at key sites will define the targets and associated mechanisms by which opioids exacerbate neuronal injury (including synaptic and dendritic pathology) and death, and neurocognitive defects (spatial learning-Morris water maze) in the hippocampus. Our long-term goal is to define the mechanisms by which opiate drug abuse exacerbates neurodegenerative and neurocognitive defects, and to identify the underlying signaling events that could be targeted therapeutically.

Public health relevance
PUBLIC HEALTH RELEVANCE: Emerging evidence suggests opioid drug abuse exacerbates the neurodegenerative effects of HIV-1 through cumulative insults that limit neuronal function long before the neuron is fatally injured. The grant proposes to examine the mechanisms underlying the functional decline of opioid-HIV-exposed hippocampal neurons involved in learning and memory. Events underlying early functional damage are likely to be reversible and may be excellent therapeutic targets. Emerging evidence suggests opioid drug abuse exacerbates the neurodegenerative effects of HIV-1 through cumulative insults that limit neuronal function long before the neuron is fatally injured. The grant proposes to examine the mechanisms underlying the functional decline of opioid-HIV-exposed hippocampal neurons involved in learning and memory. Events underlying early functional damage are likely to be reversible and may be excellent therapeutic targets. __SpecificAimsTextDelimiter__ 5.5.2. Specific Aims: Accumulating evidence suggests that opioid drug abuse intrinsically exacerbates the neuropathology of HIV-1. We have found that neuronal death is preceded by a prolonged period of synaptic culling, functional losses, and dendritic pathology that are presumed reversible. Importantly, opiate abuse potentiates the neuropathogenesis of HIV by synergistically increasing dendritic pathology (varicosity formation, beading, fragmentation, pruning), while promoting additive dendritic spine losses (plasticity). This has been verified in the striatum (spiny neurons) and hippocampus (CA1 pyramidal neurons), and synaptic pruning has been confirmed electron microscopically. Moreover, behavioral defects in both Morris water maze and rotarod performance are accompanied by synaptic losses and dendritic pathology in the absence of demonstrable neuron death, suggesting that sublethal neuronal injury and reduced synaptic connectivity underlie the ability of opioids to aggravate HIV-associated neurological disorders (HAND). These findings represent a fundamental shift in our understanding of opioid drug action and propel the grant in novel directions. While death per se is significant, the interruption of events preceding neuron death may be more strategic therapeutically. We hypothesize that opioid-HIV interactive increases in neuron death are preceded by cumulative insults to synaptic organization and function that are non-lethal and assumed reversible. The reductions in neuronal function underlie cognitive impairment in neuroAIDS, and represent a more rational therapeutic target for chronic drug abuse-HIV comorbidity. The effects of opiate drug, HIV-1 virions, gp120, and Tat-induced neurotoxicity will be assessed in hippocampal neurons co-cultured with glia, in organotypic slice cultures, and in vivo. The causal, MOPr- dependent signals driving neuronal injury or death will be identified and mechanisms underlying the neuronal injury and death responses elucidated. Aim 1. To characterize the events underlying opioid and HIV-1-dependent neuronal dysfunction and/or injury in hippocampal neurons. Aim 1 outlines a systematic assessment of opioid and HIV-1- dependent alterations in synaptic function (altered membrane properties, EPSPs, LTP), synaptic morphology (spine losses), and dendritic pathology (altered Na+, Ca2+, and ATP homeostasis, swelling or beading), preceding regulated cell death. Experiments will be conducted in hippocampal slices and dissociated culture. Aim 2. To define the excitotoxic mechanisms by which opioids exacerbate HIV-1 Tat and gp120- induced neuronal dysfunction, injury, and/or death. Guided by the findings in Aim 1, the role of specific excitotoxic pathways/events (e.g., Na+ influx via NMDA, ATP depletion, Ca2+ overload) and receptor types (NMDA and AMPA) in mediating opioid, Tat, and gp120-induced neuronal dysfunction and injury will be elucidated. NMDAR and AMPAR subtypes and excitotoxic signaling will be selectively manipulated in hippocampal dissociated neurons and slices using physical (microinjection), pharmacological, silencing, and genetic (MOPr null cells) strategies to identify mechanisms underlying neuronal dysfunction and injury. Aim 3. To identify the MOPr-expressing cellular sites of opioid action that exacerbate HIV-1-induced hippocampal neuronal injury, dysfunction and behavioral deficits in vivo. The cellular sites where opioids exacerbate the excitotoxic effects of Tat and gp120 in the hippocampus will be identified using floxed MOPr mice bred to GFAP [B6.Cg-Tg(GFAP-cre)8Gtm], myeloid (microglial) specific lysozyme 2 (B6.129P2- Lyz2tm1(cre)Ifo/J), and GABAergic forebrain neuron specific [Tg(dlx6a-cre)1Mekk/J] Cre recombinase mice. Conditionally deleting MOPr at key sites will define the targets and associated mechanisms by which opioids exacerbate neuronal injury (including synaptic and dendritic pathology) and death (TUNEL, EM), and neurocognitive defects (spatial learning-Morris water maze) in the hippocampus. We were first to show that opioid drugs could intrinsically exacerbate HIV-1-induced CNS inflammation and neuronal injury through mechanisms independent of peripheral immune suppression [56,180]. Our long-term goal is to define the mechanisms by which opiate drug abuse exacerbates neurodegenerative and neurocognitive defects, and to identify key underlying events that could be targeted therapeutically.